Core B: Biostatistics and Bioinformatics

ABSTRACT
Core B (Hu, Roe) Biostatistics and Bioinformatics
The goal of the Biostatistics and Bioinformatics Core is to facilitate the Targeted Prevention for Non-Melanoma
Skin Cancer Program Project Grant (PPG) scientific objectives by integrating strong statistical study design,
accurate and organized data, and appropriate statistical analyses and interpretation into all projects. The
Biostatistics and Bioinformatics faculty and staff will be intimately involved in the conception, design,
implementation, analysis, and reporting of research conducted in the PPG. Core B personnel work not only on
design, data management, and analysis issues, an essential role, but also develop a logical framework for the
scientific approach applied to PPG research questions and help to ensure valid interpretation of the results.
The specific aims of Core B are:
Aim 1. To provide statistical collaboration in the design, execution and analysis of all projects.
Aim 2. To develop procedures for data collection, and to build and maintain computer databases for
information storage and retrieval.
Aim 3. To provide reports on individual study progress, data for the UACC Data and Safety Monitoring
Board (DSMB), and reports for the Scientific Advisory Board (SAB) meetings.
The Core B support activities have been combined into a single core to facilitate interactions among the
biostatisticians and bioinformaticians involved in PPG projects. The interactive nature of PPG activities
facilitates the involvement of both the Biostatistics and Bioinformatics personnel within the projects. The
translational goal is to facilitate integration of project results among the basic science, clinical, bioinformatics,
and biostatistician investigators.

Public health relevance
PROJECT NARRATIVE Core B (Hu, Roe) Biostatistics and Bioinformatics The Biostatistics and Bioinformatics Core collaborates with all investigators in this Program Project by providing statistical and bioinformatics support for the design, conduct and analysis of all projects, including data management and computing support. The Biostatistics and Bioinformatics Core provides services necessary for the acquisition and dissemination of valid scientific knowledge by all projects.